Mechanism of alpha-synuclein neurotoxicity

Project Summary/Abstract Parkinson's disease (PD) imposes a major burden on our aging population, and represents a neurodegenerative disorder that affects broad areas of the brain, but primarily manifests as a loss of dopaminergic neurons in the Substantia nigra. α-Synuclein is thought to play a central role in PD because α- synuclein mutations and polymorphisms are linked to PD, and because α-synuclein containing inclusion bodies (Lewy bodies) are found neuropathologically in PD. Current data suggest that α-synuclein promotes neurodegeneration in PD by misfolding into a toxic conformation, most likely as a microaggregate, that is deleterious to the neurons harboring the toxic α-synuclein conformer. However, the mechanisms mediating the toxic effects of α-synuclein remain incompletely understood. The present project proposes to investigate the mechanisms underlying α-synuclein neurotoxicity in two specific aims, using cultured human neurons and mouse brains in situ as model systems, and focusing in particular on an understanding of the nature of α- synuclein toxicity. The project will utilize an interdisciplinary approach with a particular emphasis on electrophysiological recordings to probe the relation of neuronal function, in particular as regards synaptic transmission, to α-synuclein neurotoxicity. The results from these experiments will elucidate the extent and nature of α-synuclein neurotoxicity in mouse and in human neurons.